Cellular and molecular mechanisms of e-cigarette vaping-induced acute lung injury

Abstract
The outbreak of electronic-cigarette, or vaping, product use-associated lung injury (EVALI) has led to >2800
hospitalized patients and to >60 deaths in the US. The number of cases peaked between June and September
2019 with a subsequent reduction in trends since then. However, cases continue to occur, emphasizing the need
to understand better the underlying mechanism(s) of EVALI. Patient data has led to the hypothesis that vitamin
E acetate (VEA) in e-cigarettes can generate a toxic mixture that leads to EVALI. Recently, e-vapor generated
from liquid containing VEA has been found to induce lung injury in mice. However, knowledge gaps remain and
a need exists to investigate further this hypothesis. This proposal has assembled a team of experienced
investigators that are capable of chemical, molecular, and toxicological assessments to provide mechanistic
insights into EVALI. We have obtained the following preliminary data: A. VEA e-vapor generated from current
sub-ohm vaping devises can produce a novel reactive oxygen species: ethyl peroxyl radical. B. In primary mouse
alveolar macrophages, e-vapor extract is cytotoxic and leads to membrane blebbing. C. In RAW 264.7 cells, e-
vapor extract increases cell membrane phosphatidylserine externalization. D. In RAW 264.7 cells, e-vapor
extract activates caspase 3/7 mediated cell death that can be inhibited by the antioxidant n-acetyl cysteine. E.
In mice, single cell RNASeq implicates a number of critical events including decreased macrophage transcripts
that are regulated by interferon regulatory protein 8. The hypothesis-driven aims are: 1. Determine the chemical
culprits that produce the pathological responses of EVALI. 2. Determine the mechanism of E-vapor induced cell
death in alveolar macrophages, and 3. Determine the role of E-vapor-induced decreased interferon regulatory
factor 8 in macrophage function. In the latter aim, the mechanisms by which corticosteroid therapy used in EVALI
recovery will be investigated. Each aim considers alternative outcomes and strategies. In future studies, our
approaches could be applied to flavored e-liquid toxicology. EVALI may have mechanisms that are common to
other chemicals (e.g., acrolein or phosgene) known to induce acute lung injury in humans. Thus, the knowledge
gained about EVALI pathology and therapy could be applied broadly to chemically-induced acute lung injury.
Alternatively, EVALI may be a unique form of acute lung injury and a clearer understanding of its pathology will
provide a mechanistic basis for the targeted strategies to treat this syndrome alone.

Public health relevance
Electronic-cigarette, or vaping, product use–associated lung injury (EVALI) has led to >2,800 hospitalized patients and has led to >60 deaths in the United States. Detailed chemical analysis will be performed to identify the toxicants in e-vapor that led to EVALI. To better understand the molecular mechanisms of EVALI, mice will be exposed to constituents that have been associated with human case of lung injury. Data obtained will be used to identify the role of steroids in the treatment of EVALI. The outcome of this research could have substantial public health impact and inform the ongoing investigation into this illness as well as its diagnosis, treatment, and prevention.